Dendritic integration of spatial and object features in a Drosophila sensorimotor circuit.

Research Abstract
Single neurons perform complex computations that depend critically on the interactions between often precisely
targeted synaptic inputs and the intrinsic active and passive properties of the neuron. While some functional
implications of synaptic topography and intrinsic properties for neural computation have been explored, their
interactions remain poorly understood. Difficulties in simultaneously localizing synaptic inputs, effectively
activating synapses with realistic time courses and functional tuning, and manipulating neuron intrinsic properties,
pose challenges in exploring these interactions which collectively shape neuronal computations. This study aims
to address this gap by using a combination of computational and experimental approaches, focusing on the
looming detection circuits of the fruit fly Drosophila melanogaster, which drive motor responses to objects
approaching on a direct collision course. These circuits contain descending neurons (DNs) that integrate
overlapping inputs from visual projection neuron (VPN) populations, that encode different features of the looming
stimulus (such as angular velocity or size). By leveraging experimental access to VPNs and DNs, together with
the comprehensive electron microscopy dataset of the full adult fly brain, we develop detailed biophysical models
to investigate how the spatiotemporally realistic activation of VPN synapses influences integration processes
and interacts with intrinsic properties of DNs. Through experimental manipulations and computational
simulations, we aim to uncover the mechanisms that underlie the integration of synaptic inputs in DNs to drive
realistic responses. Overall, this study will provide insights into visual feature integration within VPN-DN circuits
and general mechanisms underlying dendritic integration.

Public health relevance
Project Narrative Neuronal computations underly information processing which are critical in driving our behavior and experiences, however, are disrupted under neurodegenerative and neurodevelopmental diseases, ultimately affecting behavior and cognitive function. Here we propose an innovative approach to investigate general mechanisms that govern the interactions between a neuron’s intrinsic properties and synaptic organization, which influence neuronal computations. A deeper understanding of neuronal computations will directly provide new perspectives to approaching neurodegenerative and neurodevelopmental disorders by providing potential new avenues for treatments.